Medical Scientist Training Program

The goal of the UCI Medical Scientist Training Program (MSTP) is to train students as
biomedical research scientists who will make advances to improve the diagnosis, understanding
and treatment of human diseases. Training is offered in a diverse number of medically related
fields. This is accomplished by means of a flexible, independently designed curriculum. MSTP
students can complete their PhD studies in any graduate program at UCI. These include
departments and graduate programs in all 14 schools and the Program in Population & Public
Health, which is in the process of becoming a school. In addition, students may carry out their
research in one of the collaborative facilities on campus that combine both basic and clinical
research, such as the Beckman Laser Institute and Medical Clinic, the NCI Chao Family
Comprehensive Cancer Center, the Institute for Clinical and Translational Science and the Sue
& Bill Gross Stem Cell Research Center. Students have pursued their graduate research in the
Schools of Medicine, Biological Sciences, Engineering, Social Ecology, Physical Sciences, and
Information & Computer Sciences, as well as the Program in Public Health. Opportunities for
research also include numerous collaborative facilities on campus that combine both basic and
clinical research, such as the Beckman Laser Institute and Medical Clinic, the Research
Imaging Center, the NCI Chao Family Comprehensive Cancer Center, the Institute for Clinical
and Translational Science and the Sue & Bill Gross Stem Cell Research Center.
Established in 1987, the MSTP has enrolled 216 students and has graduated 119. There
are currently 63 students in 20 departments across 9 schools or programs. There were 74
alumni who graduated since 2008, with 27 still in residency or fellowship training, and 1
deceased, leaving 46 who have completed their training and obtained positions. Of this group,
25 (54.4%) are in faculty positions, 3 (6.5%) are in industry (which includes a lab director), 6
(13.0%) are at academic medical centers, and 12 (26.1%) are involved exclusively in clinical
care. The program enrolls 7 new students each year using a holistic admissions process that
includes academic performance, research experience and potential, clinical experience, and
personal characteristics and experiences, including factors contributing to educational diversity.
Students have been quite productive, with an average of 6.7 papers per student and 2.9 first
author papers per student for graduates during the past 10 years. They study with faculty who
have strong training records and research grant support that averages ~$500,000 annually. All
students are fully supported.

Public health relevance
Project Narrative The goal of the UCI Medical Scientist Training Program (MSTP) is to train students as biomedical research scientists who will make advances to improve the diagnosis, understanding and treatment of human disease. Students obtain research training and complete their Ph.D. degree in any of the graduate programs at UCI, and they obtain clinical training and obtain their M.D. degree in the UCI School of Medicine. The program utilizes a flexible, independently designed curriculum for the students and provides additional activities to bridge the research and clinical fields.